GERIATRIC DENTISTRY ACADEMIC AWARD

In phase two of the Geriatric Dentistry Academic Award, the clinical and didactic aspects of the teaching program will be formalized and integrated into the senior year curriculum as a required course. The Geriatric Evaluation Group will see patients regularly, and be present in the senior clinic at least two days a week. The compilation of a multi-disciplinary syllabus in geriatric dentistry will be initiated. Cooperative efforts between the Center for Geriatrics and Gerontology will continue, with Dr. Lynn Tepper from the Center assuming the part-time position as gerontologist with the Geriatric Evaluation Group. Dr. Tillman will continue to pursue her education in geriatrics by participating in courses at the School of Public Health; and by beginning collaborative efforts to establish a foundation for areas of future clinical research.